Targeting the Nrf2 axis to reduce lung immunopathology in PolG-related mitochondrial disease

PROJECT SUMMARY
Mitochondrial diseases (MD) are a clinically heterogeneous group of disorders caused by respiratory chain
dysfunction and metabolic failure. These diseases often result from pathogenic mutations in genes that function
in oxidative phosphorylation or mitochondrial DNA (mtDNA) maintenance, are often debilitating, and have limited
treatment options with no cures. Environmental exposures, such as microbial infection, appear to exacerbate
the stepwise progression of MD. MD patients are also more susceptible to recurrent infections from opportunistic
respiratory pathogens including Pseudomonas aeruginosa (PA). Infections can quickly spiral out of control,
leading to sepsis and unrestrained inflammatory responses in MD patients. The underlying immune alterations
in MD that enhance immunopathology are unclear, constituting a key gap in knowledge that complicates
treatment and increases mortality in these patients. Thus, there is a critical need for mechanistic research to
advance immune-focused therapies for MD. Mutations in mtDNA polymerase gamma (PolG) represent the most
prevalent single-gene cause of MD. Ongoing experiments using a faithful mouse model of PolG-related MD have
uncovered novel immune alterations in PolG mutant animals. Notably, PolG mutants exhibit elevated numbers
of myeloid immune cells in the lung and increased lung neutrophil infiltration and cytokine production after
instillation of bacterial lipopolysaccharide or intranasal delivery of PA. Additional preliminary experiments
revealed that PolG mutant macrophages undergo increased pyroptosis after exposure to PA, which is driven by
elevated expression and activity of caspase-11. Prior mechanistic studies showed widespread repression of the
transcription factor nuclear erythroid 2-related factor 2 (Nrf2) in PolG mutant mice. Nrf2 orchestrates both
antioxidant and anti-inflammatory responses. Stabilizing Nrf2 with the FDA-approved drug dimethyl fumarate
(DMF) was effective at reducing inflammation in PolG macrophages exposed to live PA. Therefore, this proposal
will test the central hypothesis that loss of Nrf2 activity promotes myeloid cell hyperinflammation, lung
immunopathology, and increased morbidity and mortality in PolG mutant mice and patients with PolG-related
MD. Specific Aim 1 will test the hypothesis that elevated type I interferon (IFN-I) signaling and the subsequent
reduction of Nrf2 activity in PolG mutant macrophages promotes hyperinflammatory innate immune signaling
and inflammatory cell death via potentiated non-canonical inflammasome activation. Specific Aim 2 tests the
hypothesis that hyperinflammatory innate immune responses contribute to acute lung injury during PA infection
using a faithful in vivo model of PolG-related MD. Both Aims will incorporate in vitro and in vivo DMF treatments
to characterize how Nrf2 stabilization alleviates hyperinflammation and reduces lung pathology during PA
infection. This research will fundamentally advance understanding of innate immune defects in a relevant model
of MD. It may also lead to the development of innovative Nrf2-based therapies to slow the damaging toll of
respiratory infections and lung immunopathology in PolG-related MD or other mitochondrial disorders.

Public health relevance
PROJECT NARRATIVE Mitochondrial diseases are a group of clinically variable disorders caused by the malfunction of cellular components called mitochondria, which are responsible for generating energy that powers vital body processes. This proposal will utilize cell and animal models to investigate why patients with with mitochondrial disease are more susceptible to lung injury and inflammation after infection with opportunistic bacterial pathogens. This research will have a positive impact on public health because it will enhance our understanding of immune dysfunction in mitochondrial disease and may lead to innovative treatments that alleviate inflammatory and infectious pathology in patients with these disorders.